Control of influenza virus induced type I interferon signaling during pregnancy

PROJECT SUMMARY/ABSTRACT
Infectious insults are common during pregnancy; over the nine months of gestation ~60% of pregnant women
self-report at least one illness, with viral upper respiratory tract (URT) infections being the most common.
Although URT-trophic viruses replicate in the respiratory epithelium, the induced inflammatory cytokines like
type I interferon (IFN) circulate systemically and can access the placenta. Recent work has shown that virally
induced type I IFNs can be major drivers of adverse effects on fetal development. URT infections during
pregnancy, however, are not typically linked to birth defects or miscarriage. It was therefore unclear why
maternal infection with a pathogen like an influenza virus, which also induces to fetal IFN exposure, would not
compromise fetal health. We hypothesized that an uncharacterized IFN regulatory pathway was the answer to
this apparent discrepancy. By performing a genome-wide CRISPR/Cas screen, we identified a G-protein
coupled estrogen receptor 1 (GPER1) dependent signaling pathway that protected fetal health from type I IFN
signaling during maternal influenza A virus (IAV) infection. Disruption of this pathway led to fetal phenotypes
as severe as those caused by direct congenital infections. Importantly, the activities of this pathway were
restricted to reproductive and fetal tissues; alterations of its activity had no measurable effect on maternal
health during IAV infection. The major goal of this application is to understand how GPER1-mediated signaling
normally protects fetal health from inflammatory maternal cytokines such as type I IFN. In aim 1, we will define
how GPER1-induced GPCR signaling suppresses IFN-induced JAK/STAT signaling and interferon-stimulated
gene expression. These experiments will define a previously unknown mechanism for control of IFN signaling.
In aim 2, we will characterize where and when GPER1 signaling is required to protect fetal health, as well as
the effects of GPER1 dysregulation on cell physiology both in vivo and in primary human placental organoid
cultures. These experiments will allow basic mechanistic insights into how maternal inflammation compromises
fetal development. Finally, in aim 3, we will explore the consequences of IFN signaling on placental
structure/function when GPER1 is absent and also evaluate the potential of hyper-activating GPER1 signaling
under the inflammatory conditions that normally harm fetal development. Together, these studies will not only
allow for a more complete understanding of IFN regulatory mechanisms and the fetal/maternal immune
response but could also serve as the basis for an eventual first-in-class treatment designed to protect the fetus
from inflammation without compromising maternal immunity.

Public health relevance
PROJECT NARRATIVE Infections during pregnancy produce inflammatory cytokines (such as type I interferon) which can lead to miscarriage or birth defects; unfortunately, there are no interventions capable of protecting the fetus from this inflammation. We have identified a previously uncharacterized signaling pathway, induced by the G protein- coupled estrogen receptor 1 (GPER1), that functions to prevent type I interferons produced during a maternal respiratory infection from compromising fetal development. The major goal of this application is to define how the basal activities of GPER1 normally protect fetal health so that this knowledge can eventually be leveraged to prevent poor pregnancy outcomes.